Investigating mechanisms regulating cytoskeletal dynamics and alignment during epithelial tissue folding

Project Summary:
Large-scale tissue movements are critical during development to transform an amorphous collection of
cells into organs with specific structure and function. Abnormal activation of force-generating signals that
regulate epithelial morphogenesis can result in developmental defects, such as neural tube deformities, as well
as aberrant epithelial-mesenchymal transition and cancer metastasis. Yet we do not fully understand how
mechanical forces generated at the molecular level regulate epithelial remodeling. At the cellular level, most
forces are generated by the actomyosin network; the molecular motor non-muscle myosin II (myosin)
crosslinks actin filaments (F-actin), thereby generating contractile forces which are propagated throughout the
tissue via intercellular connections. One outcome of actomyosin contractility is apical contraction, in which the
apex of the cell narrows as a result of repeated bursts of myosin pulses that condense the F-actin cortex in a
ratchet-like manner. When myosin pulsing and ratcheting is disrupted, cells fail to apically constrict and the
tissue fails to fold. However, the mechanisms driving pulsatile contractions and ratcheting behavior remains
poorly understood, highlighting a critical gap in our understanding of how upstream signaling events are
intricately linked to downstream changes in cytoskeletal organization and behavior. The long-term goal of this
project is to determine how mechanical forces generated at the molecular level collectively drive tissue-wide
morphogenetic changes. The overall objective of this proposal is to identify mechanisms that regulate myosin
dynamics and alignment by determining the mechanistic link between Twist expression and myosin turnover.
The rationale for this proposed work is to gain insight not only into the nature of these mechanisms, but also
the general principles governing contractility and ratchet-like apical constriction during large-scale tissue
movements. Our central hypothesis is that Twist, and its downstream effectors, as well as tissue-wide forces,
via intercellular connections, cooperatively regulate myosin dynamics to drive apical ratcheting and tissue
remodeling events during embryonic development in Drosophila. This hypothesis will be tested by pursuing two
specific aims: we will (1) determine the mechanism through which Twist promotes cell apex stabilization, and
(2) determine how myosin dynamics are affected by intercellular connectivity. Our approach is innovative
because it is one of the first to directly examine myosin dynamics using an integrative strategy that combines
classic Drosophila genetics with advanced microscopy methods, including photo-conversion and super-
resolution imaging. The proposed research is significant because it will advance our understanding of the
connection between gene expression, signaling pathways, and force production during epithelial
morphogenesis, and will provide new perspective to ongoing research efforts investigating developmental
diseases and cancer biology.

Public health relevance
Project Narrative: The goal of this research plan is to uncover the regulatory mechanisms governing actomyosin contractility, the driving force behind many large-scale tissue movements, from gastrulation to epithelial-mesenchymal transition and apoptosis. The proposed research is of direct relevance to human health because the discovery of novel mechanisms controlling cytoskeletal dynamics during morphogenesis will increase our understanding of developmental defects and diseases, including cancer, that result from failures in proper tissue folding and remodeling. Thus, this research is pertinent to the part of the NIH’s mission that is dedicated to the development and application of fundamental knowledge to enhance health and reduce illness and disease.